Shared Resource - Core A: Administrative Core

Project Summary/Abstract
The goals of the Administrative core will be: 1) coordinate effective interactions among projects, cores,
oversight committees, and NCI staff, 2) provide Data safety and Monitoring support, ensuring that
clinical trials are under the highest standards of “Good Clinical Practices” and that they comply with all
the regulations of the University and other outside agencies, 3) support interactions with the Cancer
Center and the Center for Precision Surgery, 4) support interactions with Industry, and 5) provide
budget support, such as tracking the expenditures of the program and providing monthly reports to the
investigators. This Core will also monitor Projects and other Cores and organize a yearly meeting with
the External and Internal Advisory Boards. Given these broad integrative activities, the Core will interact
closely with each Project and Imaging Core in providing administrative, financial, and coordinating
activities.

Public health relevance
Project Narrative The goals of the Administrative core will be coordinate effective interactions among projects, cores, oversight committees; provide Data safety and Monitoring support; ensure clinical trials are under the highest standards of “Good Clinical Practices”; and, provide budget support.